Targeting the MUC1-C Oncoprotein in Triple-Negative Breast Cancer

Mucin 1 (MUC1) is aberrantly overexpressed in ~90% of human breast cancers, including the triple-negative
(TNBC) subtype, and is associated with poor progression-free and overall survival. MUC1 has thus emerged
as a highly attractive target for the treatment of TNBC; however, to date there are no approved agents against
this heterodimeric transmembrane protein. Therefore, what is needed now is the development of novel agents
that target MUC1 and specifically the MUC1-C subunit for the treatment of patients with refractory TNBC.
MUC1 consists of two subunits: an extracellular N-terminal mucin subunit (MUC1-N) that is shed from the cell
surface, and a transmembrane C-terminal subunit (MUC1-C) that is oncogenic. MUC1-C functions as an
oncoprotein by acting as a node for integrating signaling pathways linked to transformation. In this way,
MUC1-C drives (i) the epithelial-mesenchymal transition (EMT), (ii) the cancer stem cell (CSC) state, (iii)
tumorigenicity, (iv) metabolic alterations, (v) epigenetic programming, and (vi) immune evasion of TNBC cells.
Our work has also demonstrated that MUC1-C is a druggable target. As one approach, we have generated
first-in-class monoclonal antibodies (MAbs) against the non-shed MUC1-C extracellular domain. These MAbs
have provided a unique opportunity to develop antibody-drug conjugates (ADCs) that specifically target MUC1-
C on the surface of TNBC cells. Our MAbs are also being advanced for the development of antibody-
dependent cell-mediated cytotoxicity (ADCC) and bispecific immunotherapeutics.
In addition, we have developed agents that target the MUC1-C cytoplasmic domain and inhibit its oncogenic
function. Targeting MUC1-C with the GO-203 inhibitor reverses the EMT, CSC and tumorigenic TNBC
phenotype. Targeting MUC1-C with GO-203 also inhibits immune evasion of TNBC cells, indicating that GO-
203 could be used in combination with other immunotherapies. These findings and the development of highly
novel antibodies have collectively supported the targeting of MUC1-C as potential immunotherapeutic
approaches for patients with TNBC.
The Specific Aims are: (1) To investigate the effects of ADCs targeting the MUC1-C extracellular domain on
TNBC cells; (2) To develop an ADCC and a bispecific antibody for targeting MUC1-C on TNBCs; (3) To target
the MUC1-C cytoplasmic domain with GO-203/NPs in combination with other immunotherapeutics to
circumvent TNBC immune evasion; and (4) To analyze TNBC specimens for MUC1-C expression and the
suppressive immune microenvironment as metrics for response to MUC1-C-targeted agents.

Public health relevance
Breast cancer is one of the leading causes of death for women. The MUC1 oncogenic protein is aberrantly overexpressed in about 90% of human breast tumors and confers a poor survival outcome for patients. Our proposed research focuses on how to effectively target MUC1 function in the aggressive triple-negative subtype of breast cancer with the novel agents we have developed for the treatment of this disease.